Neural mechanisms of affective processing in prefrontal-limbic circuits

Project summary
Anhedonia is a defining symptom of mood disorders and anxiety disorders and is characterized by a loss of
positive affect from rewarding experiences. Current theories of anhedonia emphasize that it consists of two
distinct components: one is related to the expectation of reward, the other to the pleasure from receiving
rewards. Understanding how the brain processes expected and received rewards at the level of single neurons
is therefore a key challenge for basic neuroscience. Imaging studies indicate that one part of the prefrontal
cortex, the subcallosal anterior cingulate cortex (ACC) is active when rewards are expected and is altered in
individuals with anhedonia. Corroborating this finding, data from studies of monkeys with lesions of the
subcallosal ACC indicate that this area is important for behavior related to the expectation, but not the receipt
of rewards. However, no approach to date has been able to provide a circuit-level understanding of how the
subcallosal ACC influences reward expectation. This level of understanding is important as deep brain
stimulation of subcallosal ACC and nearby white matter pathways alleviates anhedonia in some patients. This
intervention is hypothesized to work by altering functional interaction between subcallosal ACC and either
amygdala or ventral striatum. Which pathway is more important for controlling behavior related to reward
expectation or the requisite activity patterns is unknown. Our goal here is to determine the neural mechanisms
engaged in the subcallosal ACC-amygdala-VS circuit when rewards are expected and then received. We
hypothesize that the role of the subcallosal ACC is to modulate reward encoding within ventral striatum and
amygdala during reward expectation, but not receipt. To test our hypothesis we will use an innovative
combination of single-neuron recordings, field potential recordings, electrical stimulation, diffusion imaging
methods, and chemogenetics analyzing the timing of reward-related neural responses and LFP coherence
among the three sites under normal physiological conditions, when neurons in subcallosal ACC are chronically
activated using chemogenetic methods, and when acute electrical stimulation is applied both under normal
conditions and when the area is chronically activated. Completing these aims will fundamentally advance our
understanding of the neural circuits and activity patterns that control reward-related behavioral and neural
activity in primates as well as providing a circuit level understanding of how subcallosal ACC influences
expected reward processing. This level of understanding has the potential to inform and help refine pathway-
specific interventions for all disorders characterized by a loss pleasure from reward, such as depression as
well as schizophrenia.

Public health relevance
Project narrative Depression is characterized by a loss of positive affect from rewarding events, and involves dysfunction across a network of interconnected brain areas centering on the subcallosal anterior cingulate cortex. How the subcallosal anterior cingulate cortex influences how rewarding events are processed at the level of single neurons is unknown. Using a novel combination of neural recordings, electrical stimulation, and MRI imaging our aim is to determine how the subcallosal anterior cingulate cortex modulates reward-related responses at the level of brain circuits.